Mechanogenetics: An Integrated Approach to Aging in Muscle Dysfunction

Project Summary
Cardiomyocytes in the Drosophila melanogaster heart tube undergo progressive loss of their intercalated disc
proteins and increased expression of extracellular matrix with age, resulting in reduced sarcomere lattice
crystallinity and thus power stroke inefficiency; maintaining inter-myofilament spacing–by upregulating cardiac-
specific expression of vinculin or downregulating matrix proteins–preserved heart wall velocity and extended life-
and health-span in a mechanism conserved in non-human primates. Recently, we also showed that nuclei stiffen
in aged hearts, reducing the amount of chromatin accessibility in key muscle transcription factors and leading to
reduced cardiac output; when expression of the nucleoskeletal protein Lamin C–which decreases with age–is
restored in aged cardiomyocytes, nuclei soften and become deformable again, prolong cardiac function, and
maintain transcription factor expression, i.e., mechanogenetics. Most importantly in aged cardiomyocytes, we
found that restoration of transcription factors alone was sufficient to maintain cardiac identity.
While our prior studies have examined these structures separately, in this grant renewal application, we propose
two further aims to investigate mechanical links between age-associated remodeling of sarcomere and nuclei.
For aim 1, we will investigate age-associated changes in the structural connections between sarcomeres and
nuclei, e.g., the Linker of Nucleoskeleton and Cytoskeleton (LINC) complex. Preliminary data suggests that
significant age-associated transcriptional and chromatin accessibility reductions in LINC genes MSP300 and
Klar–which physically connect these structures–could underlie the maintenance of deformable nuclei, Lamin C
and transcription factor expression with age, and the extension of lifespan. For a second aim, we have developed
new engineering methods to ask a critical question of aging, namely: can “exercising” the sarcomeres restore
transcription factor expression in aged hearts? Using mechanical and pharmacological perturbations, we will
challenge aged hearts to maintain force transduction, which we hypothesize will maintain soft, deformable nuclei
that will in turn preserve the chromatin accessibility of key muscle transcription factors. In light of the challenges
that mechanical forces play on gene expression, we believe that this on-going work will continue to improve our
understanding of how forces are required to maintain cardiac identity and ensure appropriate cardiac output in
the aged heart.

Public health relevance
Project Narrative Age-induced heart failure significantly impairs and is a cause of death for many thousands in the United States annually. We have developed new mechanical assays that–using the rapidly aging animal model Drosophila melanogaster–have identified proteins in and around the nucleus that appear to play critical roles in maintaining heart contractility during aging. Here, we will deepen our understanding of their molecular mechanisms and systemic benefits, which could significantly extend lifespan and improve healthspan.